Opsins and TRP channels controlling sensation and behavior in Aedes aeygpti

Abstract
The mosquito Aedes aegypti spreads diseases such as dengue, Zika, yellow fever, and others that afflict >100
million people each year. These mosquitoes rely on multiple keen senses to locate human hosts for blood
meals, and for finding conspecifics for mating. Currently, we have only a rudimentary understanding of the
receptors that control these critical behaviors. The goal of the proposed research is to address this gap. The
unifying theme of this proposal is to test the idea that opsins and TRP channels are two key classes of
signaling proteins that have broad roles in sensation and in controlling behavior in Ae. aegypti. Rhodopsins are
the founding G-protein coupled receptors (GPCRs). We recently discovered that opsins are multi-modal
sensory receptors, challenging 100 years of dogma that they detect only light. To find humans, female Ae.
aegypti integrate information from diverse stimuli, including CO2, visual cues, organic molecules, and
convection heat from skin. We discovered another cue. Aim 1 builds on our preliminary data that Ae. aegypti
use infrared (IR) radiation as an additional host stimulus. We outline experiments to reveal the roles of opsins
and the TRPA1 channel in IR detection. We propose to identify the IR-sensing neurons that express the opsins
and TRPA1, and to test a model to explain the role of opsins in IR sensation. To pursue this aim, we devised a
highly effective assay for monitoring IR attraction and a new molecular genetic approach to bypass difficulties
in combining multiple genetic elements. Aim 2 takes advantage of a mutation that we created in another TRP
(TRPV-A), which renders males and females deaf. We will test the roles of hearing and TRPV-A in swarm
formation, in mating, and in finding humans. Aim 2 will also build on the observations that male mating requires
audition mediated by TRPV-A to devise a strategy to overcome a major impediment limiting the efficacy of the
sterile insect technique (SIT). SIT is a promising strategy to suppress Ae. aegypti. It involves inundating a local
population with sterile males, which then render females sterile upon mating. An obstacle to using SIT is that
wild-type males outcompete sterile males. We propose that manipulation of the activity of the TRPV-A-
expressing auditory neurons elevates sterile male mating success, and will thereby increase the efficacy of SIT
in suppressing Ae. aegypti. Aim 3 concerns identifying the sensory receptors for repellents. We propose to test
the idea that an opsin functions as a highly sensitive receptor for insect repellents. If confirmed by the
proposed experiments, this would demonstrate that opsins comprise a new class of olfactory receptor. To
accomplish our goals, we have developed an extensive repertoire of state-of-the-art approaches. These
include new molecular genetic tools, a suite of behavioral assays, original video tracking software, and in vivo
electrophysiological recordings. In summary, this project will reveal the roles of opsins and TRP channels in
allowing mosquitoes to sense humans and conspecific mates. The insights gleaned from this work have
exciting potential to lead to innovative strategies to control Ae. aegypti and reduce insect-borne disease.

Public health relevance
Project narrative The mosquito disease vector, Aedes aegypti, is troubling because it spreads viruses that cause diseases such as dengue, yellow fever, and Zika, which infect >100,000,000 people/year. The goals of the proposed research are to define members of two classes of receptors that mosquitoes use to find humans, clarify mechanisms through which they sense repellents, and to improve a promising approach for suppressing populations of Aedes aegypti. These studies could lead to the design of new traps, deterrent devices and genetic control strategies to reduce mosquito-borne disease.